GABA signaling in the nTS and cardiorespiratory responses to hypoxia

Maintaining the balance of excitatory glutamate and inhibitory GABA signaling is critical for homeostasis and
generating proper reflexes in response to hypoxia. Our previous studies established glutamate signaling in the
nucleus tractus solitarii (nTS), the first central site for carotid body sensory integration, is exaggerated after
chronic intermittent hypoxia (CIH). However, the specific contribution of GABA, which counter-balances
glutamate signaling, in the exaggerated excitation is unknown. Our current goal is to address this knowledge
gap and determine the extent that inhibitory GABA signaling contributes to overexcitation of the nTS after CIH.
GABA signaling is controlled or modulated by GABA release, receptor (GABARs) activation, the chloride (Cl-)
equilibrium potential that is set by Cl- co-transporters (NKCC1 and KCC2), and astrocytic GABA uptake via
transporters (GATs). Given the present literature and our supporting preliminary data, our overarching
hypothesis is that CIH shifts nTS activity to an overexcited state due to attenuated GABA signaling via reduced
GABA inhibition and increased astrocyte GAT activity. Reduced GABA tips the balance of Glu and GABA
signaling, and their influence on each other (i.e., cross-talk), towards greater excitation to ultimately increase
chemoreflex responses. Aim 1 will determine the extent GABA signaling is altered in CIH to increase nTS
excitability. Working hypothesis: Reduced GABA inhibition increases nTS excitability and cardiorespiratory
function in CIH. GABA inhibition is attenuated in CIH due to reduced GABA release or GABARs on Glu
neurons, altered Cl- transport and/or augmented astrocyte GAT. Aim 2 will define the magnitude nTS GABA
and astrocyte GABA transporters influence Glu signaling in CIH to control neuronal and cardiorespiratory
function. Working hypothesis: GABA-Glu balance is shifted towards excitation after CIH, in part due to altered
GAT function, to ultimately to increase nTS excitability and cardiorespiratory function. In this application, we
will utilize a multi-faceted, synergistic and integrative approach. We will use a range of techniques including
single cell electrophysiology, live-cell imaging, DREADD cellular manipulation and molecular biology to
ultimately decipher physiological function. We will also use AAV expression and Cre-technology in transgenic
rats that allows specific recording and manipulation in GABA neurons from the single cell to whole animal.
Each technique directly complements the other, allowing an unparalleled depth of study. Together, these
techniques allow the vertical study of the system and meticulous cellular investigation. Upon completion of the
proposed research, we expect to identify the significance and mechanisms of elevated nTS activity due to
reduced GABA signaling that result in cardiorespiratory abnormalities in IH diseases.

Public health relevance
NARRATIVE Many cardiorespiratory diseases manifest as unstable breathing and episodic periods of hypoxia resulting in sympathetic-mediated hypertension; an exaggerated chemoreflex and its brain interaction are implicated in these responses. Our studies will determine the importance of altered GABA-mediated inhibition in sensory and brainstem reflex neurons in an episodic hypoxia rat model. We expect to define how targeting these brain mechanisms can be used to design rational and novel therapeutic approaches to the consequences of hypoxia.